Frequency and E-field Enhancement of iTBS for Depression (FREED)

Abstract
Treatment resistant depression (TRD) is present in about 2.5 percent of the population and is associated with
considerable personal suffering and societal costs. Repetitive transcranial magnetic stimulation (rTMS) is a safe
and effective treatment for TRD that is increasingly being used in clinical practice across the world. However,
while there is convincing evidence for the effectiveness of rTMS treatment, the overall remission rate achieved
in patients is typically considerably less than 50%. Coupled with the fact that a course of rTMS takes considerable
time to administer (up to 6 weeks), this limited efficacy substantially impacts clinical utility. Intermittent theta burst
stimulation (iTBS) is a new form of TMS that involves the patterned application of stimulation pulses in both the
theta and gamma frequencies. iTBS has recently been shown to be non-inferior to standard rTMS but can be
applied in a dramatically shorter time, typically three minutes per day compared to 20-40 minutes. However, the
use of iTBS has not been shown to enhance overall treatment efficacy compared to rTMS. Several methods are
under investigation to try to improve the efficacy of iTBS treatment, in part through the individualization of
treatment parameters. In this study, individualization of iTBS will include frequency and location optimization.
Frequency individualization involves stimulating at each patient’s endogenous brain rhythms derived from theta-
gamma coupling during a working memory task. Our findings suggest that such frequency individualization of
iTBS produces greater effects on neuroplasticity, cognitive function, and mood enhancement in healthy subjects.
Next, we have developed methods to individualize coil placement using electric field (E-field) modelling to limit
anatomic variability and maximize dosing for each patient. We will aim to individually target the TMS e-field to a
specific cortical region corresponding to Talairach coordinate (–45, 45, 35) in the left dorsolateral prefrontal
cortex (DLPFC). We also previously reported that targeting this region with rTMS produces superior efficacy
compared to conventional targeting. We now propose to undertake a 2-phase program to determine if
individualized iTBS based on frequency and E-field modelling will enhance its efficacy in patients with TRD. In
the R61 phase of this application, we will test if this novel approach produces target engagement by randomizing
75 patients with TRD to a course of frequency and location individualized iTBS, location individualized iTBS only,
or standard iTBS stimulation. We aim to establish whether individualized frequency/location iTBS produces a
greater change in theta connectivity as a demonstration of its capacity to alter activity in relevant frontal–parietal
circuitry. If this is established, we will have achieved our go-criterion and will request to proceed with the three-
year R33 phase. During this phase, we will conduct a larger scale randomized controlled trial comparing
individualized frequency/location iTBS to standard iTBS in 144 patients with TRD and compare the effects on
both target engagement (fronto-parietal theta connectivity) and clinical outcomes (depression severity). The
overall goal of this research is to develop a more effective form of iTBS treatment for patients with TRD.

Public health relevance
Intermittent theta burst stimulation (iTBS) is increasingly used as a therapy for treatment resistant major depressive disorder. We propose that the overall remission rate achieved with iTBS can be enhanced by increasing the individualization of treatment parameters including frequency and location optimization. We plan to establish target engagement in the R61 phase and clinical efficacy in the R33 phase.